Program in Hematology: Molecular & Cell Biology of Blood Cells

PROJECT SUMMARY
This application requests continued funding for a postdoctoral research training program in hematology that
has been successful in attracting young scientists and physician-scientists into academic careers in
hematology. The program has as its primary objective to prepare MD, MD/PhD, and PhD postdoctoral fellows
for productive careers in the hematology research workforce. We are requesting support for four postdoctoral
trainees per year (two PhD trainees and two MD or MD/PhD trainees), which is unchanged from the previous
grant period. Under the leadership of MPIs Steven Lentz and Anil Chauhan, the training will be carried out in
an enriched environment of active basic, translational and clinical investigation at an institution that
emphasizes the career development and collaborative science. We aim to recruit outstanding postdoctoral
trainees, of diverse gender, ethnicity and culture, who wish to obtain comprehensive knowledge of the
principles and techniques of basic and translational research related to hematology, blood cells, vascular
biology, coagulation, hematopoiesis, and immunobiology, and prepare them for successful careers as
independent investigators or related scientific positions. We have defined six specific objectives for trainees
that are linked to measurable outputs in our evidenced-based evaluation process. Upon completion of the
program, trainees will be able to: (1) Integrate knowledge of basic mechanisms, research methods, and clinical
hematology to identify the most significant and impactful research questions; (2) Demonstrate critical thinking
and reasoning in the conduct of research; (3) Demonstrate integrity and rigor in the conduct of research; (4)
Demonstrate skills in oral and written communication, including grant applications and publications; (5)
Recognize the importance of diversity, equity and inclusion; (6) Demonstrate skills in leadership and
mentoring. Several new initiatives have been instituted, including expansion of the clinical hematology
fellowship and creation of an advanced hematology fellowship track, closer partnership with the PSTP (a
robust pipeline for physician-scientist trainees), a new scientific focus on thrombo-inflammation and stroke, and
implementation of structured individualized career mentoring. The curriculum includes core lectures in clinical
hematology, research methods, RCR, rigor and reproducibility, and grant writing. Mentoring committees and
individual development plans are required for all trainees. The foundation of training continues to be centered
on the individual mentored research project, marked by a period of intensive, sustained research under the
guidance of an established, dedicated mentor. The rich training environment provided by the diverse faculty,
extensive laboratory, clinical, and core facilities, and strong institutional support should ensure continued
success in attracting and preparing highly qualified postdoctoral trainees for careers in hematology research.

Public health relevance
PROJECT NARRATIVE The training program has as its primary objective to prepare MD, MD/PhD, and PhD postdoctoral fellows for productive careers in the hematology research workforce. There is a particular need to expand the number of scientists and physician-scientists trained in research in the field of hematology because of its direct relevance to some of the most common human medical conditions, including abnormalities of immune cells, vascular diseases, disorders of blood clotting, and sickle cell disease.